J. NRSA Training

Training the next generation of health scientists to transform discoveries into benefits for clinical care will
require a strong research foundation adjoined to pioneering training programs that provide well-designed
lessons in innovation and entrepreneurship. Here, we propose a new NRSA Training Core, the Health
Sciences Innovation and Entrepreneurship (HSIE) Training Program, as a component of the CTSA
application submitted by our Translational Research Institute (TRI). Basic skills of entrepreneurial team
science will be taught to two predoctoral and three postdoctoral fellow entrants each year, who exhibit a
passion for transforming biomedical discoveries into new medications, devices, diagnostics and clinical
practices. The interdisciplinary HSIE Training Program will supplement traditional department-based research
training and engage scholars from the Colleges of Medicine, Nursing, Pharmacy and Public Health. Sixty-six of
the most innovative faculty across our hub, many involved in entrepreneurial activities, will serve on HSIE
Scholar Advisory Committees with the trainee’s primary research mentor. Individual development plans will be
formulated and harmonized with career goals. The core of the 2-year HSIE Training Program is a 15-credit
Graduate Certificate in Health Science Innovation and Entrepreneurship. HSIE Scholars will shadow health
science innovators during the first semester with “Snapshot Sessions” providing scholars with experiences
tailored to their career interests including internships and learning opportunities. The HSIE Training Program
will sponsor a 2-credit seminar series, “Health Science Entrepreneurs: Innovators of Health Care”, in
partnership with the Alabama, Kansas and Utah CTSAs. These seminars will increase entrepreneurial activity
across hubs by heightening awareness of steps required to translate new discoveries into improved health
care, and offer HSIE Scholars opportunities to interact with national entrepreneurs. Three 3-credit courses will
be offered in the evening via interactive audiovideo-conferencing by the Graduate Entrepreneurship Program
in the Walton College of Business at the University of Arkansas - Fayetteville. After learning business
principles, a Capstone Project is a gateway for teams of inter-disciplinary scholars to develop a business plan
for translating a biomedical discovery into a health care product or service. Embracing the concept that team
science will advance biomedical discoveries into improved clinical care and community health, the HSIE
Training Program plays a critical role in our hub’s vision to be a thriving translational research ecosystem that
catalyzes discoveries into health solutions for rural and under-represented populations.